Single-cell analysis of the lung immune microenvironment and cell-cell interactions across healthy and diseased patients

PROJECT SUMMARY
Lung diseases, such as asthma, are believe to arise due to alterations in cell type proportion, cellular function,
and tissue organization in different compartments of the respiratory system. Recent advances in high-
throughput single cell RNA-sequencing (scRNA-seq) have enabled comprehensive characterization of the
cellular census of the lung, which has led to a remarkable number of novel findings in new cell types and cell
states at homeostasis and in disease, including our team’s recent discovery of the pulmonary ionocyte.
However, our understanding of the cell type relationships and their higher order tissue organization is still
lacking in the context of health and disease. In 2020, over 1 million cells of scRNA-seq data from healthy and
diseased lung patients will become available, which will provide unprecedented resolution and statistical power
to study the variation in the lung microenviroment across different anatomical locations in healthy and diseased
individuals. Such an endeavor presents several computational challenges due to the high-dimensionality of the
data and because analysis tools of cellular communication in scRNA-seq data and integration with spatial
information are still at their infancy. We propose to integrate high-dimensional scRNA-seq data and correct for
batch effects between laboratories in order to build a uniformly annotated single-cell atlas of more than one
hundred healthy and asthma patients. Such an atlas would enable us to characterize the similarities and
differences in cellular composition and cell-cell interactions at different locations along the proximal-distal axis
of the healthy human lung and assess the effects of clinical correlates, such as age and smoking history, on
cellular composition and organization. Location specific lung microenvironment analysis is critical to
understand the context of lung disease pathogenesis, especially in the context of asthma. Furthermore,
comparison between the lung microenvironment in anatomically matched regions across hundreds of normal
and asthma patients will uncover commonly dysregulated cellular proportions and cell-cell interactions that can
inform on shared pathways to target therapeutically. Beyond the scope of this study, we aim to validate the
newly discovered cell-cell interactions using sequence- or fluoresce-based spatial data, that is available to our
lab through the Human Cell Atlas network and through our ongoing collaborations at Mount Sinai.

Public health relevance
PROJECT NARRATIVE Recent advancements in high-throughput single-cell RNA-sequencing (scRNA-seq) have led to remarkable discoveries in the cell types that make up the human lung and how cellular proporitions and cell states have changed in lung disease; however, our understanding of the cellular communication in normal and disease lung microenvironments is still lacking. We propose to integrate scRNA-seq data across hundreds of healthy and diseased patients and improve on existing computational methods to characterize the cell-cell interactions in different anatomical locations of the respiratory system and how they change in the context of asthma. Our integrated scRNA-seq atlas will serve as a valuable resource for the lung community and our computational framework can be applied to characterize changes in the microenviroment of chronic lung diseases, such as asthma.